Targeting cysteine import to induce ferroptotic cell death in pancreatic cancer

Abstract:
Pancreatic ductal adenocarcinoma (PDAC) is among the most lethal human malignancies and is responsible for
over 48,000 deaths per year in the United States. PDAC tumors have several genetic and physiological
properties that promote the generation of highly toxic reactive oxygen species (ROS), which can interact
destructively with cellular macromolecules. As a result, these tumors rely heavily on ROS detoxification programs
which employ thiol groups to mitigate the electron imbalances that define ROS. Those thiols are ultimately
derived from cysteine, a semi-essential amino acid with a thiol-containing side chain. As cysteine is ultimately
sourced from dietary sources, the import of exogenous cysteine is a critical step in the ROS detoxification
process. In the first term of this grant, we tested the hypothesis that PDAC depends on cysteine import for
survival. We found that depletion of cysteine, either through depletion from the media or by inhibition of cysteine
uptake, resulted in the induction of ferroptosis, a form of regulated necrosis that occurs due to oxidative damage
to cellular membranes. We demonstrated that cysteine depletion could selectively induce ferroptosis in PDAC
tumors in vivo using both genetic and pharmacological approaches and we expanded the mechanistic
understanding of ferroptosis by demonstrating that depletion of coenzyme A (a cysteine derivative) is necessary
for the induction of ferroptosis in pancreatic tumor cells.
Here we will extend these findings in order to potentiate the effects of cysteine depletion in PDAC. First, we
will study the mechanistic difference between inhibition of system xC– versus degradation of exogenous cystine
with the engineered enzyme cyst(e)inase. We will then directly compare the preclinical efficacy of these
approaches in a genetically engineered models of PDAC, making use of a new, highly potent system xC– inhibitor.
Second, we will pursue our earlier findings on the role of coenzyme A in regulating ferroptosis by studying
whether high levels of coenzyme A in the tumor microenvironment might help suppress ferroptosis in malignant
epithelial cells. This leads to a strategy of targeting ENPP proteins, which are necessary for the (indirect) import
of exogenous coenzyme A. Third, we will determine whether the release of free iron from ferritin through via
autophagy can promote ferroptosis in the context of cysteine depletion. This leads to a strategy of activating
autophagy via MEK inhibition to increase lipid ROS production and sensitize to ferroptosis in combination with
cysteine depletion. For each of these topics, we will pursue both basic science mechanisms and translational
strategies. The studies will make use of genetically engineered mouse models of PDAC as well as novel tumor
explant models developed by our group in which human or murine PDAC samples are cultured intact in an
engineered system for up to a week. Together, these studies will further elucidate the mechanisms of response
to cysteine-depletion strategies in pancreatic ductal adenocarcinoma.

Public health relevance
Project Narrative We previously demonstrated that pancreatic tumors depend on the amino acid cysteine in order to prevent cell death through a process called ferroptosis. Here we propose to improve the anti-cancer effects of cysteine depletion by targeting complementary aspects of tumor metabolism and immunity. These proposed studies will also further illuminate the mechanisms of cysteine depletion and ferroptosis in pancreatic cancer.